BioSystems Networks and Translational Research - Insights into Inflammation (BioSNTR-II)

PROJECT SUMMARY – OVERALL
The goal of this proposal is a coordinated, synergized, and integrated COBRE research program, called the
“BioSystems Networks and Translational Research – Insights into Inflammation (BioSNTR-II),” at South
Dakota State University (SDSU), Brookings, SD. Our research objective is to improve human health by
advancing the understanding of molecular, cellular and tissue-level mechanisms of inflammation research via
multi-disciplinary approaches. The overarching hypothesis is that intracellular regulatory events are governed
by cell-cell communication across the macrophage, stromal and lymphatic axes during the inflammatory
response and its resolution. Junior research project leaders, mentored by senior faculty, define the three
research projects of BioSNTR-II in the areas of: macrophage cell biology in inflammation, the role or primary
cilia in regulating lymphangiogenesis in inflammation and regulation of tumor necrosis factor signaling and cell
death pathways. These projects will be supported by two cutting-edge research cores in (1) transcriptome
sequencing, analysis and model development (Transcriptome and Network Analyses Core) and (2) CRISPR-
based gene editing and Integrated Microscopy and Gene Evaluation (CRISPR-IMAGE). In addition, an
Administrative Core is proposed to support the fiscal and personnel management, implementation, oversight
and evaluation of both the research projects and the cores. The synergy and integration of these components
has been carefully planned to maximize impact while supporting training, professional development, and the
career potential of a cadre of bright, promising basic researchers. The Center will achieve success through the
following aims: (1) Develop and manage a thriving environment for inflammation research at SDSU, (2)
Establish new Research Cores to expand and enhance biomedical research at SDSU, and (3) Guide center
performance and sustainability with assessment and advisory board input.

Public health relevance
NARRATIVE This proposed Center Of Biomedical Excellence is relevant for public health because it will improve molecular and cellular mechanistic understanding of inflammatory processes. This work is relevant to the mission of NIH in that the fundamental knowledge of inflammation generated by the center, will provide new strategies for regulating inflammation in numerous disease states and inflammatory conditions.